Optimizing self-monitoring in a digital health intervention for weight loss

PROJECT SUMMARY/ABSTRACT
Behavioral obesity treatments can produce clinically significant weight loss but are often too costly or intensive
to be implemented on a large scale. Standalone digital health interventions offer greater scalability than
traditional in-person approaches, but produce only modest weight loss. To maximize efficacy, it is vital to
determine the “active ingredients” of an intervention and eliminate the ineffective, or even detrimental, ones.
Self-monitoring is a core component of behavioral obesity treatment that can be delivered via digital tools, yet
little is known about the unique and combined impact of different self-monitoring strategies. The K23
candidate, Dr. Michele Patel, will address this gap by applying an innovative framework – the Multiphase
Optimization Strategy (MOST) – to identify the most potent combination of digital self-monitoring strategies for
weight loss. As the first part of this programmatic line of research, Dr. Patel will conduct a 6-month optimization
trial that randomizes 176 adults with overweight/obesity to 0-3 self-monitoring components (tracking dietary
intake, physical activity, and/or body weight) using a full factorial design. This study will leverage existing
commercial platforms for self-monitoring, including a mobile app, wearable activity monitor, and wireless
electronic scale. All participants will also receive an empirically- and theory-informed core weight loss
intervention that includes goal setting, weekly tailored feedback, action plans, and behavioral skills training –
components that enhance engagement and are well-supported by prior research. Aim 1a will examine the
optimal combination of self-monitoring strategies that maximizes 6-month weight loss while Aim 1b will
examine self-monitoring engagement and its association with weight loss. Aim 2 will evaluate barriers to and
facilitators of engaging in these self-monitoring strategies, which will be assessed via semi-structured
qualitative interviews with 40 trial participants. Aim 3 will assess a novel, interactive recruitment strategy via an
embedded trial. Together, results will inform an R01 grant that evaluates the newly optimized intervention in an
RCT. Building on Dr. Patel’s background in clinical trial methodology and behavioral obesity treatment, the
proposed career development award will provide substantive training in 1) MOST and factorial designs; 2)
qualitative and mixed methods research; 3) innovative recruitment and retention strategies; and 4) preparation
for the transition into independent research. To facilitate successful completion of these goals, Stanford
University’s outstanding environment for interdisciplinary research will be coupled with a highly-qualified, well-
rounded mentorship team comprised of Primary Mentor Dr. Abby King, Co-mentors Dr. Gary Bennett and Dr.
Lisa Rosas, and Consultants Mr. John Gallis (biostatistician) and Dr. Linda Collins (developer of MOST). This
K23 will position Dr. Patel to become a leader in optimizing digital interventions for weight loss and will launch
her career as an independent investigator dedicated to treating obesity through innovative solutions.

Public health relevance
PROJECT NARRATIVE Creating an effective and scalable weight loss intervention is fundamental to treating obesity on a population level. This proposal seeks to optimize a standalone digital intervention for weight loss by identifying which self- monitoring components (tracking diet, physical activity, or body weight), alone or in combination, maximize success while minimizing burden. This line of work has potential for important public health impact by enhancing weight loss in digital treatments that can reach broad populations of adults with overweight/obesity.